Understanding Emerging artemisinin partner drug resistance in eastern Africa

ABSTRACT
Malaria remains a significant public health challenge, with 234 million cases and 593,000 deaths in Africa in
2021. The emergence of partial resistance to artemisinin in Africa will likely worsen this situation leading to
failure to control the parasite with the main frontline drugs artemisinin combination therapies. Arteminsinin
resistance also will likely lead to resistance to partner drugs used in combination. Evidence suggests that
resistance to lumefantrine, the partner drug in the most common ACT in Africa, artemether-lumefantrine (AL),
is also emerging. Our proposal leverages multiple parasite lines from UK travelers who failed AL therapy,
including isolates with high-level stable lumefantrine resistance, to investigate resistance mechanisms. We aim
to gain insight and understand the underlying cellular and genetic alterations associated with lumefantrine
resistance using multi-omics, murine genetic crosses, and CRISPR technology. We will achieve this through
the following specific aims:
Specific Aim 1: Conduct a detailed analysis of in vitro phenotypes and genome variation in P. falciparum
isolates from African patients who failed AL treatment from the UK research biobank. Using two high-level
resistant, intermediate and sensitive parasites, we will clone these parasites by limiting dilution to ensure
purity and phenotype them through standard IC50 testing. Targeted sequencing of known drug resistance
genes will identify potential mutations, and isolates will be assessed for gametocyte production for use in
genetic crosses. This aim will create a well-characterized renewable resource related to lumefantrine as well
as artemisinin resistance
Specific Aim 2: Determine genomic, transcriptional, and translational differences associated with reduced
lumefantrine sensitivity. Using well-defined isolates from the UK Malaria Reference Lab, we will perform
telomere to telomere genome sequencing, single-cell RNA sequencing, bulk RNAseq, and proteomics to
identify stage-specific expression changes and potential causative mutations. We will use CRISPR gene
editing to evaluate the impact of known MDR1 and CRT mutations as well as other discovered candidates on
lumefantrine resistance.
Specific Aim 3: Identify quantitative trait loci (QTLs) associated with stable in vitro lumefantrine resistance
through genetic crosses in humanized mice with human hepatocyte grafts. We will cross lumefantrine-resistant
parasites with complementary drug-susceptible parasites, analyze recombinants under drug pressure, and
perform QTL mapping. CRISPR editing will validate the polymorphisms associated with lumefantrine
susceptibility.
This comprehensive investigation will yield a valuable extensive bank of characterized isolates, actionable
molecular markers, and insights into the mechanisms of lumefantrine resistance, advancing our understanding
and control of malaria lumefantrine resistance.

Public health relevance
NARRATIVE Malaria treatment is threatened in Africa where the vast majority of cases and deaths occur. A key drug is lumefantrine for which there is evidence of developing resistance. We aim to rapidly understand the mechanism and genetic underpinnings towards informing control efforts and devising countermeasures.